Regulation of cytoskeletal reorganization by a single effector during Chlamydia infection

ABSTRACT
Chlamydia trachomatis (Ct) is the most common cause of bacterial sexually transmitted infections worldwide.
Frequent reinfection due to the lack of protective immunity can result in considerable reproductive consequences
such as pelvic inflammatory disease and infertility. Without a prophylactic vaccine, it is paramount to identify the
intracellular survival strategies of C. trachomatis and how they impact pathology and disease progression. Thus,
our long-term goal is to determine how interactions between Ct and its host contribute to virulence and result in
pathological outcomes.
Ct is an obligate intracellular bacterium that replicates within a parasitic niche called the inclusion. Ct hijacks
various host pathways to weave actin and microtubule cytoskeletal scaffolds around the inclusion. Microtubule
scaffolds then become post-translationally modified (PTM-MT), which is critical for positioning Golgi ministacks
around the inclusion, allowing Ct easier access to lipids. In contrast, actin scaffolds form a physical barrier to
prevent the premature lysis of the inclusion and the release of bacteria into the cytosol. Interestingly, Ct utilizes
a single effector protein, InaC/CT813, to coordinate the formation of these functionally distinct scaffolds.
However, how InaC directs the formation of each scaffold, as well as their role in vivo, remains unknown.
Identifying the contributions of each cytoskeletal scaffold to Ct pathogenesis has been hampered by the inability
to selectively inactivate the different scaffolds. To overcome this obstacle, we have generated a unique library
of InaC mutants that are defective in either PTM-MT or actin scaffolds. Using our InaCmutant Ct library, we will test
the hypothesis that distinct protein domains generate different cytoskeletal scaffolds, which are important for Ct
development and pathogenesis in vivo. For the first time, we will be able to establish the importance of individual
cytoskeletal scaffolds in Ct development and how they contribute to virulence both in vitro and in the animal
model.

Public health relevance
HEALTH RELEVANCE Chlamydia trachomatis is the most common etiological agent of bacterial sexually transmitted disease and is the leading cause of infectious blindness worldwide. Chlamydia hijacks multiple cytoskeletal elements using a single effector protein to promote its survival in host cells. Understanding how Chlamydia accomplishes this task and the importance of these cytoskeletal scaffolds in vivo will provide much-needed insight into the virulence factors that influence disease progression and could guide the development of novel therapeutic strategies.